High-Dimensional Regression for Data Integration

Project 1: High-Dimensional Regression for Data Integration
Abstract
Associated with high-dimensional omic (e.g. genomic, transcriptomic, epigenomic) features there is a
rich set of functional and regulatory annotations, pathway information, and disease-specific knowledge
from previous studies that is routinely used to interpret analyses of omic data. In this project, we
propose to develop integrative regression methods capable of incorporating this array of external
information a priori, rather than post hoc, to improve prediction performance, selection of predictive
and associated features, and to gain insight into potential biological mechanisms in studies with high-
dimensional omic data. In our first Specific Aim we propose a general high-dimensional mixed
modelling framework for integrating meta-features (e.g. functional annotations, pathways) into omic
studies, with the flexibility to handle quantitative, categorical, and time-to-event outcomes, as well as
the ability to accommodate correlated data through the inclusion of random effects. Our proposed
approach brings together mixed modeling, high-dimensional regularized regression, and an empirical
Bayes strategy that makes the direct estimation of tuning penalty parameters from the data analytically
and computationally tractable. The proposed integrative models can be deployed in ‘predictive mode’
to develop diagnostic and prognostic signatures, or in ‘discovery mode’ to identify omic features
associated with disease outcomes. We also propose an accompanying set of tools for inference and
model interpretation. Our second Specific Aim focuses on integrative high-dimensional regression
models for transcription-wide association studies (TWAS). We propose to leverage recent advances
linking enhancers and other DNA regulatory elements and their proximal target genes to improve the
prediction of genetically regulated gene expression with the goal of boosting the power and localization
ability of TWAS. In our third Specific Aim, we focus on applications of the methods in Aims 1 and 2 to
several cancer datasets.

Public health relevance
Project 1: Narrative Associated with high-dimensional omic features there is a rich set of functional and regulatory annotations, pathway information, and disease-specific knowledge from previous studies that is routinely used to interpret analyses of omic data. In this project, we propose to develop integrative high-dimensional regression methods capable of incorporating this array of external information a priori, to improve prediction performance, selection of predictive and associated features, and to gain insight into potential biological mechanisms.